PORTABLE COMPUTER-BASED INTERROGATOR FOR SLEEP DISORDER

The objective of this contract is to develop monitoring technology to accurately screen patients on an outpatient basis by monitoring physiologic variables capable of indicating whether or not there is a need for furthers more costly, sleep disorder testing. The Contractor shall perform the following: 1) evaluation of data presentation requirements to establish the basis for a multiple test battery consisting of the multiple sleep latency test (MSLT), the unprepared simple reaction time test and a patient subjective evaluation test; 2) applied use of application-specific-integrated circuits (ASIC) based digital signal processing algorithms for the identification of sleep-related electrophysiological events; 3) establishment of subject response procedures to provide a data acquisition and recording protocol, and 4) integration of a proof-of-concept system for development and extensive testing in the Phase II program.